Beta Cell Regeneration by Reprogramming of Adult Pancreatic Cells

DESCRIPTION (provided by applicant): The overall goal of this proposal is to identify means for improving β-cell regeneration in the adult pancreas. With previous BCBC funding we have developed a transgenic model of inducible total or partial β-cell ablation (RIP-DTR). In these mice, β-cell regeneration occurs after near total β-cell loss, and this relies on the transdifferentiation of adult mature α-cells to β-cells. In this proposal we will test, among different aspects, i) whether β-cell regeneration in RIP-DTR mice can be enhanced by promoting the observed spontaneous α-to-β-cell conversion. β-cell regeneration occurs by β-cell replication in other diabetes models of less severe β-cell ablation. Regeneration in RIP-DTR mice is less efficient than in these mouse models probably because DT treatment leaves almost no β-cells (DT stands for diphtheria toxin, the agent used to induce β-cell ablation in these mice). Accordingly, β-cell repopulation principally occurs in RIP-DTR mice by a mechanism of α-cell reprogramming. One of our objectives will be ii) to determine if age plays a role in β-cell regeneration / α-cell reprogramming , since proliferation in islets has been shown to profoundly decline in older rodents and humans. In addition, we will examine the molecular mechanisms controlling α- to β-cell transdifferentiation in RIP-DTR mice. These analyses will be performed in parallel with studies aimed at iii) exploring whether cell fate reprogramming is a common feature of different adult pancreatic cell types, and is not restricted to ? - cells only. The heterologous origin of new β-cells is particularly interesting, since the almost complete β-cell depletion achieved in RIP-DTR mice recreates a condition very similar to the situation found in Type 1 diabetic patients. PUBLIC HEALTH RELEVANCE: Understanding the mechanisms of β-cell regeneration and identifying the cells and factor(s) that enhance the formation and/or growth and/or survival of β-cells should have a high impact on the development of new treatments for human T1D.